Macula densa NOS1 and transplanted renal graft function

Kidney transplantation is a life-saving procedure for patients with end-stage kidney
disease. Although the short-term organ survival post-transplantation has improved dramatically
over the past decades, the long-term outcomes remain unsatisfied with the survival half-lives for
transplanted renal grafts still about 10 years. In addition, organ shortage is a global crisis which
has stimulated new approaches on expansion of the donor pool by using marginal organs.
However, the employment of marginal organs has a significantly higher incidence of delayed graft
function and lower graft survival rate compared with standard criteria donors. Therefore, there is
an urgent need for new strategies to improve the long-term graft outcomes.
In this proposal, a novel hypothesis that rescue macula densa NOS1 expression by
renal alkalization with bicarbonate improves transplanted graft outcomes will be tested.
The findings of the present proposal will provide a novel strategy with potential
translational significance that could be applied to either donors or recipients during kidney
transplantation. Additionally, the underlying mechanisms and potential targets will be examined.
Renal alkalization to enhance the expression of macula densa NOS1 expression in donors or
recipients is anticipated to be a simple and effective method that is used in the expansion of the
donor pool and improvement of long-term graft survival.

Public health relevance
Kidney transplantation is a life-saving procedure for patients with end-stage kidney disease, however, the long-term survival shows only a small improvement in recent decades, with a half-life of about 10 years and organ shortage is a global crisis. The present proposal will examine the significant role of macula densa NOS1 on the long-term renal graft function.